Assessing the impact of acquired immunodeficiency on congenital Zika virus

Project Summary/Abstract Zika virus (ZIKV) is likely to become endemic and pose a sustained threat to pregnant women in areas where human immunodeficiency virus (HIV) infection is also common. This concern motivated the NIH to initiate “Prospective Cohort Study of HIV and Zika in Infants and Pregnancy” (HIV ZIP) -- an interna- tional, 4-6 year, 2,000 person clinical study to examine the impact of HIV/ZIKV co-infections on pregnant women and their infants. The purpose of this grant is to complement HIV ZIP by rapidly obtaining companion data from highly controlled studies of macaque monkeys. Specifically, we will: Aim 1: Evaluate adverse pregnancy outcomes in rhesus macaques infected with simian immunodefi- ciency virus (SIV) only, ZIKV only, both SIV and ZIKV, and neither SIV nor ZIKV. As in the HIV ZIP trial, SIV-infected macaques will be virologically suppressed using antiretroviral drugs. All 24 pregnancies will be monitored carefully throughout gestation for adverse pregnancy outcomes including spontaneous miscarriage, prolonged ZIKV viremia, SIV-associated disease, and ZIKV neuropathogenesis. Aim 2: Define impacts of in utero SIV and ZIKV infections on infant growth, hearing, vision, and neu- rodevelopment in the first year of life. Because macaques develop more quickly than humans, abnor- malities that occur by one year of age may presage future impacts in children born with congenital Zika syndrome (CZS). Aim 3: Assess incidence of vertical transmission of SIV and ZIKV. Comprehensive necropsies of new- borns will be performed at one year of age and more than 60 tissues will be examined for the presence of SIV and ZIKV viral RNA, as well as negative-sense ZIKV RNA replication intermediates. This study is made possible by our large network of collaborators who have extensive experience study- ing both SIV and ZIKV in macaques. Data from this study will inform HIV ZIP and provide an early indi- cation of whether babies born to HIV+ women are at enhanced risk for CZS.

Public health relevance
Project narrative The NIH recently initiated a prospective, international, multiyear clinical study to evaluate the risks posed by Zika virus when pregnant women are also infected with human immunodeficiency virus. This grant proposes a companion study in rhesus macaques to complement the clinical trial. By studying macaques infected experimentally with Zika virus and simian immunodeficiency virus, maternal and infant outcomes can be evaluated using sensitive, exactly timed measurements not possible in human volunteers.